Establishment and Characterization of Novel Mutant Mouse Models for the Addiction Research Community

PROJECT SUMMARY/ABSTRACT
Addiction is an enormous economic, personal, and social burden, costing over $600 billion per year in the U.S.
Understanding vulnerability to addiction, and developing effective therapies, requires identifying the genes and
pathways that mediate the addiction process. Our long-term goal is to develop novel genetic models for
addiction-relevant phenotypes, and use these models to characterize the genetic mechanisms of addiction. We
propose to leverage the Jackson Laboratory Knockout Mouse Project 2 (JAX KOMP2) pipeline to prioritize
addiction gene candidates, and then characterize the effects of candidate gene knockouts on addiction-related
behaviors and on addiction-relevant tissues. The JAX KOMP2 Phenotyping Center performs high-throughput
phenotyping of knockout mice across organ systems using an efficient, broad-based testing pipeline including
behavioral assays for emotionality and sleep, both predictive of addiction phenotypes. Here we propose to
exploit this rich KOMP2 dataset to select a subset of lines with emotionality and neuronal phenotypes (e.g.
deviant open field, light dark, hole board, tail suspension, prepulse inhibition, rotarod, electroconvulsive seizure
threshold, or sleep phenotypes) and lacking metabolism and physiology phenotypes. Our preliminary data
provide compelling evidence that gene deletions leading to emotionality phenotypes in the KOMP pipeline
have addiction phenotypes. We will subject these lines to deep drug abuse–relevant phenotyping, including
drug self-administration, transcriptional profiling from key neuronal tissues, and whole brain imaging. The data
from these will be integrated using systems analysis. The successful completion of this project will yield dozens
of novel mouse models with detailed transcriptome, and neuroanatomical profile to establish mechanistic
insight into this behavioral abnormality. These can serve are a resource for the research community for
therapeutics development.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Discovering the genes and mechanisms that make one individual more vulnerable to addiction than another is key for designing better therapeutic interventions. Here we propose to create dozens of new mouse models for addiction that we will characterize for addiction behaviors, brain structure, and gene expression profiles in key brain regions known to regulate addiction. Successful completion of this project will yield rich datasets and mouse resources that can be exploited by the entire addiction research community to discover novel therapeutics for addiction.